Single cell tri-omics: High coverage simultaneous profiling of DNA, RNA, and proteins in single cells

ABSTRACT
Alzheimer's disease, a devastating neurologic disorder, accounts for 60-80% of all dementias, making the
development of new technologies for studying the disease crucial. Fluid Discovery aims to advance single-cell
proteomics with a groundbreaking product called Self-Assembled Partitioning Proteomics (SAP-pm), which will
quantify thousands of proteins in hundreds of thousands of individual cells and can be multiplexed with single
cell DNA and RNA sequencing. Building on cutting-edge work in microfluidics, biophysics, and genomics, SAP-
pm offers a unique, rapid, and cost-effective method to overcome limitations in protein coverage and sensitivity
found in current technologies. The project comprises two aims: (1) Develop SAP-pm for sensitive, thousand-plex
analysis of proteins at the single cell level, and (2) Expand the capability of SAP-pm to analyze brain nuclei and
simultaneously capture mRNA, facilitating valuable insights from primary human tissues to improve human
health.

Public health relevance
NARRATIVE Fluid Discovery aims to commercialize a single-cell proteomics approach, Self-Assembled Partitioning Proteomics (SAP-pm), for Alzheimer's research – enabling the quantification of thousands of proteins in hundreds of thousands of individual cells, while being multiplexed with DNA and RNA sequencing. This innovative approach overcomes limitations of existing technologies and allows for tri-omic profiling, shedding light on the mechanisms of proteomic dysregulation and unveiling new therapeutic targets.